Defining human xenoglycan-specific B cells

Glycans are a common target of antibody responses. Antibodies against foreign glycans, known as xenoglycans, can protect against highly glycosylated pathogens but can contribute to allergic and inflammatory diseases, such as alpha-gal syndrome, a tickborne disease, and Crohn’s Disease. Therefore, B cells targeting xenoglycans can be harnessed for vaccination and immunotherapy to promote or limit their production of antibodies. However, the B cell subsets and molecular mechanisms underpinning xenoglycan reactivity remain poorly defined. We previously found that humans commonly generate an antibody response against an egg-derived glycan (4S-LacNAc) present in seasonal influenza vaccines. We identified that 4S-LacNAc specific monoclonal antibodies (mAbs) demonstrate some features of natural antibodies produced by B1 cells in mice. However, key distinctions between 4S-LacNAc mAbs and natural antibodies in mice suggest xenoglycan-reactive B cells are a distinct population in humans. Moreover, 4S-LacNAc specific B cell clones could be recalled from year to year, suggesting the establishment of immune memory. To study xenoglycan-reactive B cells, we have generated a blood group antigen A (BGA) specific tetramer. From non-type A human peripheral blood mononuclear cells, we found BGA-specific B cells fell within antigen-experienced B cell subsets. Whether xenoglycan-specific B cells are a distinct B cell subset or are similar to protein-reactive antibodies remains unknown. We hypothesize that xenoglycan-reactive B cells exist within functionally distinct B cell subsets that are primed for antibody secretion relative to protein-reactive B cells and that xenoglycan-specific antibodies utilize restricted repertories, are affinity-matured, and highly specific to a single glycan. First, we will determine if xenoglycan-reactive B cells reside within a distinct memory B cell pool relative to protein-reactive to B cells (Aim 1). Using tetramers for blood group antigens A and B, alpha-gal, tetanus-toxoid, and hemagglutinin, we will perform spectral flow cytometry to determine if there are phenotypic differences between antigen-specificities. Using this information, we will sort these discrete B cell populations to determine if they are enriched for other glycan specificities. We will next determine if these cell populations have increased receptor signaling relative to B cell subsets enriched for protein reactivity. Next, we will define the repertoire and cellular features of B cells targeting common xenoglycans (Aim 2). Using the tetramers described above, we will determine if xenoglycan-reactive and protein-reactive B cells have unique repertoire features and molecular signatures. Next, we will generate mAbs to test if these B cells are undergoing affinity maturation or displaypolyreactivity. Together, the results of this project will provide critical new insight into the nature of glycan-reactive B cells and will inform how these specificities can be targeted by vaccination and immunotherapy, including totreat the tickborne disease alpha-gal syndrome.

Public health relevance
Glycan reactive antibodies are highly abundant in circulation, but our understanding of the B cell subsets and molecular means by which antibodies bind glycans remains poorly defined. In this study, we will determine the cellular subsets, repertoires, and specificities of B cells targeting foreign glycans. The results of our study will provide important new insights into how humoral immunity is generated against glycans, which can inform vaccination and immunotherapies that specifically target glycan-reactive B cells, including those that cause the tickborne illness alpha-gal syndrome.